IOF Management Core

If selected to serve as the IOFM Core, Dr Broide (Project Lead IOFM Core) and the University of California San Diego School of Medicine will ensure that there is timely disbursement, reporting, and monitoring of opportunity funds as part of requested disbursement of funds from the University of California San Diego to other institutions.